Multisensory Development: Cortical-Midbrain Interactions

Project Summary
A major issue of ignorance in sensory processing is how the brain develops its remarkable ability to use its
senses synergistically, a critical requirement for normal perception. We do know however, that acquiring this
capability is a protracted postnatal process, and the ability to use visual and auditory information cooperatively
must be learned. This process is best understood in terms of the detection and orientation behaviors mediated
by the superior colliculus (SC), a midbrain structure well-endowed with multisensory neurons. After extensive
visual-auditory experience, animals show enhanced visual-auditory detection and localization behaviors. Their
multisensory SC neurons show similar changes – now integrating their different sensory inputs to enhance
their response and the physiological salience of the initiating events. The brain has come to treat these cross-
modal stimuli as a coherent whole rather than as a set of competitive or unrelated cues. These changes are
not seen in animals reared in darkness or with masking noise, and chemical lesions preferentially eliminating
SC multisensory neurons eliminate the enhanced multisensory detection and orientation behaviors without
disrupting responses to their individual component cues. Interestingly, this integrative capacity and its
performance benefits in detecting and orienting to external events can be acquired in dark-reared and noise-
reared animals by giving them appropriate experience later in life. But, the conceptual and practical use of this
information is limited by a poor understanding of the factors underlying its acquisition and operation.
We suggest the acquisition of this SC capacity does not depend on forming generic associations between the
sensory modalities as is widely believed. Rather, it involves a far more sophisticated form of statistical learning
in which the probability that any set of cross-modal inputs derive from the same event is encoded. This
information is then used by the circuit to determine how it will later respond to such events. But to be effective
in this regard, those cross-modal inputs must access the SC through unisensory projections from association
cortex (and be filtered by the SC’s inherent biases). We posit that this natural process can be reproduced
artificially by inducing covariant activation of these converging cortico-SC afferents - in the absence of external
cues, and without any of the reinforcement contingencies or cognitive factors normally associated with overt
behavior. Finally, we hypothesize that NMDA receptors provide the crucial mechanistic basis for encoding this
experience by initiating Hebbian-like learning algorithms. The end result is a multisensory system that is
extremely sensitive to the particular cross-modal stimulus configurations that were learned to belong to the
same events. This gives them preferential access to the neural machinery that will still further enhance their
physiological salience and their ability to elicit SC-mediated behavior, ensuring that the system is adapted to
the environment in which it was formed, and in which it will likely be used.

Public health relevance
Project Narrative The ability to integrate cues from different senses in everyday situations is compromised in many individuals with brain trauma or a variety of developmental disorders (e.g., Schizophrenia, Autism Spectrum Disorder, Sensory Processing Disorder, Dyslexia, ADHD, as well as those with congenital visual or auditory dysfunction), and has a substantial negative impact on the lives of large numbers of Americans. Thus, our ignorance about how the brain acquires this capability is not only an issue of fundamental concern for Basic Science, but an impediment to developing better diagnostic and rehabilitative strategies for these individuals. Results of the experiments proposed here will provide essential information to understand the acquisition of this capability, thereby facilitating strategies to correct its defects in these individuals.